Leukocyte TelomerE Dynamics, Gender, Menopause, Insulin Resistance and Survival

DESCRIPTION (provided by applicant): Leukocyte telomere length (LTL) is a complex genetic trait. LTL undergoes attrition with age and is associated with a host of aging related diseases and environmental conditions that diminish the human lifespan. Moreover, LTL forecasts mortality in the elderly. Cross-sectional studies have established that LTL is shorter in adult men than women and in individuals with cardiovascular diseases than in their healthy peers. LTL is also relatively short in individuals who are smokers, sedentary, overweight or of low socio-economic status. Collectively, such observations suggest that LTL is a biomarker of human aging. The two elements that contribute to leukocyte telomere dynamics are LTL and its age-dependent attrition rate. Whereas considerable information is available about LTL, little is known about the links between LTL attrition rate and aging related diseases. This project will resort to a longitudinal model in same-sex twin pairs to test the following central hypotheses: (i) Age-dependent leukocyte telomere attrition is faster in men than in women and in post-menopausal than pre- menopausal women; (ii) Leukocyte telomere attrition rate is faster under conditions of increased oxidative stress/inflammation, which are often associated with increased insulin resistance and diminished circulating IGF-1; (iii) In the elderly, LTL but not age-dependent telomere attrition rate is a predictor of mortality. This feature explains in part the longer lifespan of women than men; (iv) Age-dependent leukocyte telomere attrition is heritable. These hypotheses will be tested in two cohorts of Danish twins: the Geminakar Study and the Longitudinal Study of Aging Danish Twins (LSADT). The following are the project's specific aims: 1) Examine leukocyte telomere dynamics by Southern blots and real time-PCR measurements of telomeres, based on two occasions that span 10 years in adult twins (aged 18-63 at the baseline examination) and explore the roles of gender and menopause in telomere attrition and their links with obesity, insulin resistance, IGF-1 and indices of oxidative stress/inflammation; 2) Examine the links between leukocyte telomere dynamics and mortality/survival, based on leukocyte telomere measurements on two occasions, spanning 10 years, in elderly twins (at least 73 years old at the baseline examination). We will also explore the role of CMV and EBV infections in LTL dynamics. In a subset of the elderly, we will evaluate by flow FISH telomere signal intensities in CD8+ and CD4+ cells. Findings will refine our understanding of human telomere biology and its connections with aging and lifespan.

Public health relevance
PUBLIC HEALTH RELEVANCE: In this study we will examine whether the rate of telomere shortening in leukocytes records the risk for the development of insulin resistance in adults and forecasts mortality in the elderly. We will also examine whether the rate of telomere attrition is faster in men than in women and in post-menopausal than pre-menopausal women. Our findings will provide a new insight into the gender gap in human longevity (women live longer than men) and the role of insulin resistance in the human lifespan. Project Narrative In this study we will examine whether the rate of telomere shortening in leukocytes records the risk for the development of insulin resistance in adults and forecasts mortality in the elderly. We will also examine whether the rate of telomere attrition is faster in men than in women and in post-menopausal than pre-menopausal women. Our findings will provide a new insight into the gender gap in human longevity (women live longer than men) and the role of insulin resistance in the human lifespan. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS LTL is a complex genetic trait. At any age, it is a record of two highly variable factors, namely, birth LTL and its attrition rate afterward. In just a few years epidemiological research has established connections between LTL and both aging-related diseases and environmental circumstances marked by diminished life expectancy. This research has primarily resorted to cross-sectional studies, which found that LTL is equivalent in newborn boys and girls but shorter in adult men than women. LTL is shorter in individuals with atherosclerotic cardiovascular diseases (CVD) and dementia than in their peers. Environmental factors also impact leukocyte telomere dynamics, as LTL is shorter on average in cigarette smokers than in non-smokers, in persons of lower than upper socio-economic status (SES), in obese than non-obese and in sedentary than physically active persons. Importantly, recent research unequivocally shows that shortened LTL forecasts mortality in the elderly. We offer the following broad paradigm for the nexus between LTL and human aging: Birth LTL is one of the parameters that define the oldest age that might be attained by the individual, based on his/her genetic endowment under favorable environmental circumstances that reduce extrinsic mortality. However, the rate of LTL attrition, which is influenced by both genetic and environmental factors, is an indicator of whether this landmark is reached. Given that throughout adulthood there exists a gender gap in LTL, telomere attrition rates with age must differ between women and men. To test several elements of this model, we will resort to a longitudinal rather than a cross-sectional design, focusing on the effects of gender, menopausal status, indices of obesity, insulin resistance and IGF-1 on leukocyte telomere dynamics. What is more, by studying same-sex co-twins, we will be able to explore concordance and discordance in leukocyte telomere dynamics and their links with metabolic phenotypes in adults and mortality in the elderly. In this way we will have a better understanding of telomere biology in individuals who age differently. Accordingly, we offer 5 hypotheses: Hypothesis 1: Age-dependent LTL attrition is faster in men than women and in post-menopausal than pre-menopausal women. Hypothesis 2: Insulin resistance denotes accelerated LTL attrition rate, as it is associated with altered fat mass and distribution, and increased oxidative stress/inflammation. Hypothesis 3: Lower levels of circulating IGF-1 and IGFBP3 denote accelerated LTL attrition rate because they are associated with increased oxidative stress/inflammation. Hypothesis 4: In the elderly, LTL but not LTL attrition rate is a predictor of mortality. Hypothesis 5: Age-dependent LTL attrition rate is a heritable trait. We will test these hypotheses, drawing on two unique longitudinal studies in Danish twins: the Geminakar Study and the Longitudinal Study of Aging Danish Twins (LSADT). Our specific aims are: Aim 1: Examine leukocyte telomere dynamics based on LTL measurements (by Southern blots and RT-PCR) on two occasions, 10 years apart, in adult twins from the Geminakar Study (aged 18-63 at the baseline examination) and explore their links with gender, menopause, indices of obesity, insulin resistance, IGF-1/IGFBP3 and a number of markers of oxidative stress/inflammation. In addition, we will examine associations between LTL dynamics and EBV/CMV seropositivities. Aim 2: Examine leukocyte telomere dynamics based on LTL measurements (by Southern blots and RT-PCR) on two occasions, spanning a 10 year period, in elderly twins (at least 73 years old at the baseline examination) from the LSADT and explore their links with mortality and IGF-1/IGFBP3. In addition, we will examine associations between LTL dynamics and EBV/CMV seropositivities and their impact on survival/mortality. In a subset of the cohort, we will examine telomere signals in CD8+CD28+, CD8+CD28-, CD4+CD45RA-CD45RO+ and CD4+CD45RA+CD45RO- cells. Testing the 5 hypotheses will facilitate understanding variations in aging trajectories and lifespan and the impact of gender, menopausal status, oxidative stress/inflammation and IGF-1 metabolism on these parameters among humans.